Burden and Risk of Neurological and Cognitive Impairment in Pediatric Sickle Cell Anemia in Uganda (BRAIN SAFE II)

Abstract
Despite potentially effective stroke prevention strategy for children with sickle cell anemia (SCA)
through risk screening and implementing targeted intervention, about 25% under age 12
develop clinically "silent cerebral infarcts" (SCI) - an MRI-based diagnosis not associated with
neurologically apparent strokes. SCIs may impair cognitive function and school performance,
and increase risk for overt stroke. Moreover, screening for stroke risk and reduced SCA
cerebrovascular injury through disease-altering therapies are not widely available in Sub-
Saharan Africa (SSA). In our current trial in Uganda of hydroxyurea (HU), “BRAIN SAFE II
(BS2)” (1R01HD09655), we hypothesize that HU therapy over 2.5 years may prevent or
stabilize SCA-associated brain injury, including cognitive dysfunction. Baseline MRI-MRA
imaging performed in a random sub-sample (N= 90), demonstrated >1 cerebral infarcts in over
60%, of whom most had normal TCD. Alternative non-imaging screening modalities for pediatric
SCA cerebrovascular injury – e.g. using blood-based biomarkers - are needed for targeted
intervention, especially in SSA. In a pilot study using blood samples from our prior cross-
sectional study, we assessed 4 blood-based brain biomarkers which are used in non-SCA
adults for detecting brain injury, e.g. stroke. One of these biomarker levels, neuro-filament light
chain (NfL), was significantly associated with MRI-detected infarcts, even among children with
normal screening for stroke risk. With supplemental funding, in the 90 SCA participants with
MRI-imaging at enrollment, we propose to: AIM 1. Replicate and better characterize our findings
of higher NfL levels in participants at enrollment with: (a) MRI-detected cerebral infarcts overall
and in sub-groups with or without normal stroke risk screening (replicate) and (b) Impaired
neurocognition (characterize); AIM 2. Quantify longitudinal changes in NfL and the 3 other brain
biomarkers while on HU therapy, and assess the relationship to cerebrovascular injury and
cognitive impairment at trial midpoint and completion compared to baseline. Associations
between NfL and other brain biomarkers and SCA cerebrovascular injury would support further
investigation into blood-based alternatives to risk screening and MRI imaging, and potential use
in assessing impact of interventions on cerebrovascular health in children with SCA.

Public health relevance
Narrative In this application for supplemental funded, we are proposing to assay levels of specific blood-based brain biomarkers, elevated in non-sickle cell adult stroke, using plasma samples obtained longitudinally obtained in our current trial. To support Aim 3, biomarker levels will be used to test associations with abnormalities in abnormal arterial brain blood flow, neurocognitive impairment, overt stroke as well as brain infarcts detected on magnetic resonance imaging.